Laser Scanning Confocal Microscope

PROJECT SUMMARY/ ABSTRACT
To achieve our research and education aims we request funds to purchase a Zeiss LSM 900 confocal
laser scanning microscope. Our current confocal microscope is over 20 years old and is no longer supported by
the vendor; therefore, there is no access to parts or updates for the outdated, malfunctioning software. A new
confocal microscope will advance the research of three major users at California State University, Sacramento
(Sacramento State), Drs. Monica Gonzalez, Kimberly Mulligan, and Sharon Furtak, who rely on confocal
microscopy in their research programs, which are each centered on delineating cellular and molecular etiologies
of neurodevelopmental and/or neurodegenerative diseases. PI Gonzalez measures the neurotoxicity of
pesticides by determining their impact on various neuronal substructures in cultured neurons; Dr. Mulligan
investigates the neurodevelopmental impact of air pollutants by examining different aspects of neurogenesis in
Drosophila; and Dr. Furtak examines the neural circuitry of episodic and emotional memory through molecular
manipulations of the rodent perirhinal cortex. In addition, students enrolled in the upper division undergraduate
course, Developmental Biology (BIO 127), will use the confocal microscope as part of a course-based
undergraduate research experience (CURE) where they will investigate the cellular-level impacts of
environmental chemicals on Drosophila spermatogenesis and oogenesis. The confocal microscope will also
enhance the research of three minor users who study topics including pheromone homeostasis, blood-barrier
dysregulation in diabetes and Alzheimer’s disease, and the electrical features of neurons related to their
morphology. This instrument will equip researchers with the magnification and resolution necessary to
quantitatively analyze their samples. The AI assisted sample focusing and navigation will make the confocal
microscope more accessible to students with limited microscopy experience. The associated Zen software and
motorized stage will allow researchers to set up imaging experiments that can run autonomously, enabling them
to work on other tasks or attend classes, making more efficient use of their time. These added capabilities will
expedite our research progress and stimulate the design of innovative experiments to fully leverage its potential.
The acquisition of this confocal laser scanning microscope will provide Sacramento State students access to
modern equipment for training in advanced microscopy techniques in both courses and research labs. The
instrument will also advance faculty research programs and reduce costs to researchers by eliminating the need
to pay user fees for confocal microscope access at another institution. As more research groups incorporate
microscopy into their work, we aim to establish an advanced imaging center that will serve the research and
educational needs of the entire university. By engaging students in research that will be facilitated by the
requested confocal microscope, we will thoroughly equip students with skills necessary for success in their
further educational or professional endeavors.

Public health relevance
PROJECT NARRATIVE We request funds to purchase a confocal laser scanning microscope. This microscope will enable our research groups to measure the effects of air pollution and pesticides on brain health and to further our understanding of neurodevelopmental and neurodegenerative diseases such as autism and Alzheimer’s. In addition to advancing research in these areas, students at Sacramento State will be equipped with the skills necessary to use latest instrumentation, making them competitive candidates in the job market.